Precision Medicine Policy and Treatment (PreEMPT) Model II

Integration of genomic sequencing into everyday medical practice has already begun. In our first funding period, Precision Medicine Policy and Treatment Model (PreEMPT) I, we began exploring the benefits and risks associated with genomic sequencing in newborns, which has compelling logic: It can provide clinically actionable insights to prevent illness altogether or to facilitate early detection of illnesses in childhood or adulthood. Notwithstanding the clinical utility of newborn genomic sequencing and cascade testing of family members, questions remain: cost-effectiveness of newborn genomic sequencing, long-term effects on disease morbidity and mortality, and diagnostic and treatment-related costs. These knowledge gaps are important to fill given expectations about widespread applications of genomic sequencing.
Our proposed research will create PreEMPT II by extending our existing computer microsimulation model developed in PreEMPT I to reflect the impact of newborn genomic sequencing on a wider array of childhood-onset diseases and their long-term consequences into adulthood. Additionally, we will refine our approach to considering the impact of targeted screening of siblings of children with pathogenic variants. Previously, we developed a framework to evaluate newborn genomic sequencing for pediatric cancer and cardiac diseases. In this renewal, we will extend this framework to evaluate the clinical benefits and cost-effectiveness for neuromuscular and metabolic diseases such as Duchenne muscular dystrophy and acid sphingomyelinase deficiency and as well as other diseases such as malignant hyperthermia. To highlight critical knowledge gaps, we will use value of information analysis to identify high-priority research studies within the rapidly evolving area of genomic medicine with a focus on addressing health concerns for all populations. We will enhance our existing simulation model to synthesize the best available clinical, epidemiologic and economic data, and use our analytic framework to project both short- and long-term outcomes associated with alternative screening strategies and assess the potential value of genomic sequencing for universal improvement in disease outcomes.
Our interdisciplinary team includes experts in simulation modeling, health economics, genomics, pediatrics, predictive modeling, health policy, and health systems research. We propose a highly innovative application of modeling methods to genomic technologies with the goal of synthesizing available clinical and epidemiological data into a unified modeling effort. The goal is to project long-term outcomes by incorporating evolving data in genomic sequencing for newborns to permit ready evaluation and guidance for clinical care in the United States over the next decades.

Public health relevance
With hundreds of genetic tests becoming available for clinical use, adding genomic sequencing for all newborns at birth to predict and prevent future diseases is becoming a possibility. Our research aims to extend the Precision Medicine Policy and Treatment (PreEMPT) Model – a sophisticated computer model capable of simulating short- and long-term clinical benefits and estimating the cost-effectiveness of integrating different genomic sequencing strategies into clinical care for newborns for a wide variety of heritable conditions – to evaluate outcomes through adulthood and in testing of siblings of newborns with mutations. We will also identify factors that influence the value of newborn genomic sequencing with the goal of improving medical care and health outcomes for all populations.